Neural circuit mechanisms that support the transformation of sensory inputs into number coding

Project Summary
Number sense, the cognitive ability to represent and manipulate numbers, is found across various species,
including mammals, birds, and insects, and is crucial for their survival. Among various species, number sense
is particularly important for humans for their social and economic activities. People with numerical disorders,
such as dyscalculia, which affects 3-5% of the population, face significant challenges in their lives. Despite the
importance of number sense, the underlying neural circuit mechanisms remain poorly understood. Previous
studies with monkeys have found neurons in the parietal and prefrontal cortical areas that selectively respond
to specific numbers. These number coding neurons are the candidate neural substrates for numerical
perception. However, the neural circuit mechanism that generates and maintains the number coding remains
unknown. Understanding of the mechanism is crucial to understand the basis of numerical disorders and
develop effective treatments. This research program investigates the neural circuit mechanisms that are
responsible for the transformation of visual inputs into number coding in the brain. The vision-to-number
transformation process involves multiple cortical areas spanning from sensory to association areas. To
understand how sensory inputs are transformed into numbers across the cortical hierarchy, we developed
novel head-fixed number discrimination behavior tasks for mice using virtual reality (VR). By combining the
head-fixed VR tasks with a large field-of-view 2-photon calcium imaging and optogenetics, we will reveal how
the brain transforms the extracted visual features into number coding and how the number selectivity is formed
through inter-areal and local neural circuits. These animal experiments will be corroborated with network
simulations using artificial intelligence (AI) trained to perform the same VR tasks. The results from this project
will provide critical insights into the neural basis of number sense, an essential aspect of human intelligence,
by revealing the transformation mechanism that bridges the gap between sensory and cognitive systems.
Furthermore, our unique approach to combine large-scale in vivo imaging, optogenetics, AI-based network
simulations, and novel virtual reality tasks that are compatible with training both mice and AI has the potential
to become a powerful approach to understand neural mechanisms underlying cognitive functions that involve
many brain areas in general. Therefore, the success of our project will have a broad impact on systems and
cognitive neuroscience, and on the development of more effective treatment for number-related disorders.

Public health relevance
Project Narrative People with dyscalculia, impaired numerical abilities, are facing significant challenges in their daily lives because numerical abilities are essential for human social activities and career development. Effective treatments for number-related disorders are missing due to the lack of our understanding of the underlying neural mechanism for number sense. In this project, we will reveal the neural circuit mechanisms underlying the generation and maintenance of number sense, which can guide the development of more effective treatment for number-related disorders.